Translational Epigenomics in Gastrointestinal Cancer

PROJECT SUMMARY
Gastro-intestinal (GI) cancer is a significant public health burden in the US. Among GI cancers, colorectal cancer
(CRC) has been a focus of attention because it is the third most common cancer in the US. CRC arises through
a polyp to cancer progression sequence, driven by molecular alterations (gene mutations and epigenetic
alterations) in the normal colon cells, as well as by other factors including the tumor microenvironment, gut
microbiome, etc. The identification of these molecular alterations and determination of their role in the etiology
and behavior of CRC is incomplete and under active investigation. Another GI cancer that has received
considerable attention recently is esophageal adenocarcinoma (EAC) because of its three-fold increase in the
last few decades and because of its poor prognosis (20% 5-year survival). Like CRC, EAC arises secondary to
gene mutations and epigenetic alterations that drive the formation of a pre-malignant condition called Barretts
esophagus (BE) that can then progress to EAC. Although progress has been made in the prevention and
management of GI cancers, there remains a substantial need to advance our understanding of the molecular
pathology of GI cancers and to develop biomarkers that will translate into improved cancer screening programs,
better patient management and outcomes. In order to address this need, the Research Specialist Dr. Ming Yu
has developed this research plan to achieve the following objectives: 1) Characterize and functionally
interrogate epigenetic alterations, in particular DNA methylation changes, during the initiation and
progression of GI cancer; 2) Assess methylated genes as potential molecular biomarkers. This research
plan is an integral part of the research programs that the Unit Director, Dr. William Grady, has developed at the
Fred Hutchinson Cancer Research Center (FHCRC) (PQC1R01CA194663; PQ6R01CA220004), and several
multi-disciplinary NCI funded research networks (the Early Detection Research Network (EDRN; U01 CA086389-
08), the Barrett’s Esophagus Translational Research Network (BETRNet; 5U54CA163060), and a Bridging the
Gap UO1 (5U01CA182940)). Furthermore, this plan represents unique lines of investigation that Dr. Yu has
initiated and will be leading in the next five years. These new investigations include the characterization of
enhancer methylomes, the DNA methylation changes at gene enhancer elements, during GI cancer imitation
and progression; the identification and the functional validation of onco-enhancers, and development of
organoids derived from normal and cancerous gastrointestinal tissues to study DNA methylation during cancer
initiation and progression. These approaches will provide an exciting addition to the existing research programs.
Dr. Yu, the Research Specialist in this proposal, is the principal scientist successfully leading the studies of these
research programs in the Grady laboratory at the FHCRC and has been the central determinant of success of
the Grady lab over the last few years. Dr. Yu has a central role as an “integrating node” scientist in the EDRN,
BETRNET and other multi-investigator team projects. In this Research Plan, Dr. Yu will conduct a comprehensive
assessment of DNA methylation changes during cancer initiation and progression, using whole genome bisulfite
sequencing (WGBS), which provides unprecedented coverage of CpGs across genomes at single CpG
resolution. She will integrate WGBS data with RNA-seq, CHIP-seq and clinical data of the same samples to gain
insights into the features of a candidate onco-enhancer, and test the innovative hypothesis that aberrant DNA
methylation at enhancer regions in cancer is the predominant way aberrant methylation in cancer regulates gene
expression. To elucidate whether DNA methylation at candidate oncoenhancers affects target gene expression,
she will develop CRISPR-Cas9 based DNA methylation editing tools to target enhancer regions and assess the
biological relevance of DNA methylation alterations in cells from normal and cancerous tissues. Of note, she has
established methods to culture 3-dimentional organoids from primary colon epithelium and CRC, which represent
the most relevant ex vivo culture system to date. Moreover, she will also discover and validate promising
methylated gene biomarkers that will function as biomarkers for BE and EAC, as well as CRC field cancerization
loci. Dr. Yu will capitalize on her productive collaborations in the EDRN and BTRNET to successfully develop
these biomarker assays. Prominently, she will apply a novel technology MethyLight Droplet Digital PCR that she
developed to advance the identification of an innovative set of methylated DNA markers of colon cancer risk,
termed ‘field cancerization markers’. Successful completion of the proposed studies will lead to novel insight into
the roles of epigenetic alterations in molecular pathogenesis of GI cancer. Furthermore, these findings will be
translated into the discovery of DNA methylation biomarkers that can improve the management of GI cancer.

Public health relevance
PROJECT NARRATIVE Gastro-intestinal (GI) cancer is a significant public health burden in the U.S. Two of the most prominent cancers of the GI tract in the U.S. are colorectal cancer and esophageal adenocarcinoma. Colorectal cancer (CRC) is the second leading cause of cancer deaths, and esophageal adenocarcinoma (EAC) has been the fastest increasing cause of cancer deaths over the past four decades. Consequently, the development of robust translational cancer research programs is urgently need in order to more rapidly advance our understanding of the biological mechanisms of GI cancer development into the clinical care arena so that we can more effectively prevent and treat cancer. This award will provide support for an exceptional translational cancer research scientist, Dr. Yu, to perform studies that will advance our understanding of epigenomic alterations in the initiation and progression of CRC and EAC, and accelerate the development of biomarkers for these cancers. The proposed studies aim to 1) Improve our understanding of the molecular changes during cancer initiation and progression; and to 2) Develop molecular biomarkers that can improve management of GI cancers. ! the prevention and